UW Center for Translational Muscle Research

ABSTRACT - OVERALL
The University of Washington (UW) Center for Translational Muscle Research (CTMR) will continue to provide
critical resources and programs to enhance productivity of investigators to address multi-scale and
multidisciplinary research of muscle disease and treatment strategies. Our research and clinical faculty at the
UW, Seattle Childrens and the Fred Hutch Cancer Research Center have expertise in muscle disease and aging,
exercise, and neuromuscular plasticity. The overall goal of the CTMR is to provide a unifying force to this Seattle
area research community and beyond that accelerates innovative research by providing research tools, facilities,
and expertise in a combination available only at the UW. This will facilitate novel insights into muscle pathologies
and move new therapeutics towards the clinic and the marketplace.
The CTMR offers 4 cores, one administrative and three research resource cores. The Administrative Core (A)
provides program management and enrichment through symposia and workshops, seminar series, training and
educational opportunities for new investigators and more experienced investigators moving into muscle
research. It also administers a very successful Pilot Awards program that provides funding resources to test
ideas, develop approaches and collect data that can be used for follow-on extramural research applications or
ongoing projects. The Resource Cores feature multi-scale (physical and temporal) measurement and analytical
tools. The Mechanics and Devices Core (B) provides state of the art measurements of muscle biomechanics at
multiple levels of integration and develops new assays for maturation and assessment of early-stage muscle.
The Metabolism and Energetics Core (C) provides tools for in depth measures and analysis of metabolomics,
energetics, cell respiration and mitochondrial function. The Quantitative Analysis Core (D) provides
computational and statistical tools for understanding mechanisms of function and dysfunction with disease and
suggesting new therapeutic targets. The ability to gain information at multiple scales - from protein to organelles,
cells, tissue, and organ - across energetic, metabolic, structure and functional domains using experimental and
quantitative analytic tools with integrative capacity is a powerful approach that is not easily available to an
individual investigator or research group. Such an interdisciplinary approach offers the capacity to accelerate
research to better understand skeletal muscle aging, injury and diseases and speed therapeutics development.
In the first 4 years, the CTMR has been significantly impactful on training and establishing new investigators
in muscle research and facilitating movement of more established investigators into new research areas. The
Resource Cores have developed or purchased new instrumentation and assays to meet the changing needs of
CTMR faculty. In this renewal proposal we summarize forward looking efforts to remain at the forefront of
research and development, so that - with essential support from the P30 – the CTMR will continue to meet the
needs and be an indispensable resource for our growing muscle community.

Public health relevance
NARRATIVE - OVERALL Skeletal muscle dysfunction represents a significant and growing public health concern due to reduced quality of life and loss of independence for those affected. Muscle dysfunction and degeneration result from numerous pathological conditions including genetic diseases like muscular dystrophy and systems level conditions like diabetes, cancer and aging. The UW Resource Center for Translational Muscle Research (CTMR) will provide access to, and training on state of the art tools to recruit new investigators, accelerate research and disseminate news of exciting new successes in understanding and treating skeletal muscle dysfunction to improve the health status of the U.S. population.